Mechanisms of epithelial-mesenchymal crosstalk in intrahepatic biliary formation

Project summary
Currently, there is no cure for intrahepatic bile duct (IHBD) paucity except for liver transplantation. IHBD paucity
causes accumulation of pathologic bile within the liver resulting in bile stasis and over time can lead to chronic
cholestasis. Diseases such as Alagille syndrome (ALGS), biliary atresia, progressive familial intrahepatic
cholestasis, alpha1-antitrypsin deficiency, primary biliary cirrhosis, and primary sclerosing cholangitis are
associated with IHBD paucity. The standard of care for some of these diseases includes reducing bile acids
through surgical biliary diversion, inhibition of the ileal bile acid transporter (i.e., IBAT) or by altering the
composition of the bile acid pool (using bile acids salts or FXR ligand agonists) to interrupt and modify
enterohepatic circulation. Currently, there are no clinical approaches to augment IHBD architecture or bile duct
number in patients with these diseases. Therefore, in the absence of new approaches, patients with IHBD paucity
will remain dependent on liver transplantation as definitive therapy for the foreseeable future.
We have published that hepatocyte-to-cholangiocyte transdifferentiation in the absence of epithelial Notch
activity is competent through a Tgfbr2-dependent mechanism. However, hepatocyte-to-cholangiocyte
transdifferentiation is inefficient in patients with ALGS, due to global JAGGED1 (JAG1) haploinsufficiency with a
significant number of patients requiring liver transplantation. Recent lineage tracing and single-cell RNA
sequencing studies inform us that even though arising from a common mesenchymal progenitor, the identity of
periportal mesenchyme is divergent from hepatic stellate cells and a critical knowledge gap in all aspects of
IHBD development. Preliminary work strongly supports a role for periportal mesenchyme in this process, but the
underlying role of periportal mesenchyme in IHBD paucity is superficial at best, especially regarding the
mechanisms regulating biliary epithelial-periportal mesenchymal crosstalk. Our long-term goal is to understand
the mechanisms regulating epithelial-mesenchymal crosstalk during IHBD specification, morphogenesis,
maintenance, and response to injury/disease. Based on published and unpublished results we propose to
address the central hypothesis that Jag1 haploinsufficiency impacts the periportal mesenchyme indirectly by
reducing Notch activity in the hepatic epithelium hindering the implementation of the full cholangiocyte
transcriptional program and thereby influencing the periportal mesenchyme by disrupting optimum crosstalk
between the epithelium and mesenchyme. Our aims are to: 1) define the role Gli1 periportal mesenchyme plays
to regulate epithelial IHBD development, and 2) define the role epithelial Ihh plays to regulate epithelial-periportal
mesenchymal crosstalk. Long-term, the improved understanding of epithelial-periportal mesenchymal crosstalk
will enable the development of targeted therapies capable of altering and augmenting IHBD disease.

Public health relevance
Public health narrative The bile ducts are microscopic and large tube-like structures that carry bile. Many bile duct diseases are associated with the loss of these bile ducts resulting in chronic liver disease. Currently, there is no cure or clinical treatment to augment the number or architecture of bile ducts. Our work suggests that bile duct-stroma crosstalk guides and patterns cell type specification, bile duct formation, and response to injury. Leveraging several novel tools that we have developed we aim to identify the role and underlying components of bile duct cell-stroma crosstalk and their impact on bile duct loss and biology.